CRDF Support to fund international research in challenging locations

NSF agreement for support of scientific activities related to biomedical and behavioral research managed by the Civilian Research and Development Foundation (CRDF). This will provide small peer-reviewed grants to US and international scientists to facilitate their collaboration on research topics of priority to NIAID.